Trans-ethnic meta-analysis of blood pressure in African and European ancestries

DESCRIPTION (provided by applicant): Hypertension is a leading cause of global disease burden, mortality and disability, contributing to a greater risk of cardiovascular disease, stroke and chronic kidney disease. African Americans are disproportionally affected by hypertension and its complications. Whether these racial/ethnic differences in hypertension risk are related to genetic factors is currently unknown. Studies of individuals of diverse ancestry have provided evidence for presence of additional common variants in the population with broad effects across ancestries, which could be leveraged for gene discovery in trans-ethnic meta-analysis. Using genome wide association study data from the COGENT-BP and CHARGE-BP consortia, we propose to perform trans-ethnic meta-analyses of blood pressure traits in individuals of African and European ancestry for variant discovery and fine mapping of loci, by leveraging trans-ethnic differences in allele frequencies and the patterns of linkage disequilibrium. We will examine the evidence for association of the most significantly associated blood pressure variants with clinical relevant cardiovascular disease and kidney outcomes in collaborations with established consortia. Findings from this study could have a broad impact on gene discovery and fine mapping of loci, and may provide information on genetic determinants of racial/ethnic disparities to guide strategies for prevention and treatment of hypertension and its complications.

Public health relevance
PUBLIC HEALTH RELEVANCE: High blood pressure is a leading cause of global disease burden, mortality and disability, contributing to a greater risk of coronary heart disease, stroke and chronic kidney disease. Identification of genetic factors influencing inter-individual variance in blood pressure can provide insights to the development of drug targets and ultimately be used to reduce the burden of hypertension and its complications.